Measurements and modeling of the hemodynamic response function in human cerebral cortex

Summary Brief periods of neural activity trigger a mixture of vascular and metabolic responses with somewhat stereotypical dynamics. This hemodynamic response function (HRF) is heavily used in functional magnetic resonance imaging (fMRI). While the HRF is usually assumed to be spatially invariant, detailed measurements show that its dynamics exhibit significant temporal variability; such variability confounds standard linear analysis of fMRI measurements. Nonetheless, the variability likely reflects changing interactions between blood flow and oxygen metabolism that could provide critically useful information about brain function. Thus, it is of strong interest to better understand the physics and physiology of the HRF. We developed and validated the Arterial Impulse Model (AIM) that combines a novel flow description with compartmental, 1D, convection-diffusion oxygen transport. We propose further development and validation of the model, coupled with detailed investigation of the HRF. Experimentally, we use multi-sensory stimulus protocols to evoke the HRF broadly across the brain, and evaluate the responses using high-resolution arterial spin labeling and fMRI to examine the character and variability of these responses across the brain. We will expand our model to explain the biomechanical basis of this HRF variability in a far richer framework than previous models, with the potential to transform fMRI from a rough neural correlate to a quantitative measurement of cerebral blood flow and metabolism. We will also develop a clinical application of our whole- brain HRF methods to evaluate early Alzheimer’s Disease (AD) or Mild Cognitive Impairment. Our simple, hour-long fMRI evaluation has strong potential to provide a prospective biomarker of AD pathology.

Public health relevance
Project Narrative We need a better understanding of the hemodynamic response function, the stereotypical response of the brain to brief neural stimulation. Such understanding is critical to the proper use and interpretation of brain imaging techniques that rely on neurovascular coupling and may have utility as a diagnostic for brain diseases. We propose further development of a novel model for the transient delivery of oxygen to brain tissue, together with efforts that test and validate the model’s predictions against precise local measurements of functional MRI contrast and flow changes induced by brief neural stimulation.